STRUCTURE OF RIBONUCLEIC ACIDS

DESCRIPTION: Knowledge about the three dimensional structure of ribonucleic acids (RNAs) and ribonucleoprotein particles (RNPs) is essential for understanding how they carry out their biological functions, which include RNA processing and the translation of the genetic information of messenger RNA (mRNA) into protein sequences. Such understanding could offer opportunities for pharmacological or genetic intervention in these critical processes. This proposal describes the development of three dimensional models for RNAs and RNPs, with emphasis on the ribosome and tmRNA. The ribosome is the site of protein synthesis in the cell, while tmRNA is the product of the ssrA gene in bacteria. tmRNA combines functions of both transfer RNA (tRNA) and mRNA and is used to terminate translation of messages lacking a stop codon, to release the ribosome for recycling, and to tag the truncated protein product for degradation by cellular proteases. The studies on ribosomal structure/function relationships will incorporate all available high resolution data from x-ray crystallography and nuclear magnetic resonance into models matching the density maps from cryo-electron microscopic (cryo-EM) reconstructions of ribosomes trapped at various points in the translational cycle. Dr. Harvey seeks to understand the structural, energetic and kinetic basis of translational fidelity and of translocation. The tmRNA research will include studies of the molecule free in solution, using transient electric birefringence and molecular modeling, along with cryo-EM investigations of tmRNA structure / function relationships on the ribosome. This research will include development of a library of RNA structural motifs derived from the Nucleic Acid Database, along with tools for incorporating these motifs into structural models.